Development and Application of Model Systems to Study Extrachromosomal DNA Generation in Glioblastoma

PROJECT SUMMARY/ABSTRACT
Glioblastoma (GBM) is the most common primary malignant brain tumor with little improvement in patient survival
in past few decades despite aggressive treatment options. Better understanding of the mechanisms underlying
GBM is necessary to design more effective therapeutic strategies. Extrachromosomal DNAs (ecDNAs) are a
well-known mechanism of oncogene amplification that promotes rapid tumor growth. Although discovered
decades ago, recent technological advances have characterized ecDNAs in finer detail and have shown that
they are a common occurrence in many cancer types. In a pan-cancer analysis, patients whose tumors had
ecDNA amplifications were found to have significantly shorter survival than patients whose tumors had other
types of amplifications. A recent study using GBM patient tumor tissues, their derivative cell lines, and orthotopic
xenograft mouse models generated from these lines, showed that the majority of oncogene amplifications in
these systems are extrachromosomal. Indeed, studies have shown that around 60% of GBM tumors contain
ecDNAs, making it the cancer with highest ecDNA prevalence. Mechanisms that enable ecDNA generation at
such high rates in GBM are starting to be revealed; however, no model systems are currently available to causally
analyze the role of specific genes in their generation. In Aim 1, we will therefore utilize a drug resistance
mechanism that allows ecDNA generation to develop clonal lines from primary patient-derived GBM cells to
model ecDNA generation. These systems will be isogenic (i.e., without/before and with/after ecDNA generation)
and clonal to minimize intercellular heterogeneity in ecDNA levels. Procurement of clones before and after
ecDNA generation, and knowledge of clones that are able to generate ecDNAs in this approach, combined with
desired manipulations of genes of interest permits assessment of causality of those genes in the generation
process. Using these model systems developed, we will test a hypothesis in Aim 2 that DNA repair machinery is
necessary for ecDNA generation with specific DNA repair genes governing the process. There is increasing
evidence implicating DNA repair in ecDNA generation. Moreover, DNA repair is actively being studied as a target
for GBM treatment due to its well-documented role in resistance to standard therapy for GBM via repair of
therapy-induced DNA damage. The causal role of key DNA repair genes in ecDNA generation will be analyzed
by determining the effects of CRISPRi-induced repression of these genes on ecDNA generation. We expect that
the findings from this project will help define the ecDNA generation process and the therapeutic potential of
targeting ecDNA in GBM with implications for other cancers with high ecDNA prevalence.

Public health relevance
PROJECT NARRATIVE Cancer growth is fueled by high levels of certain genes, which, when located on extrachromosomal DNA (ecDNA) in cancer cells, provide further growth advantage to cancer cells. The mechanisms that enable the formation of ecDNAs are poorly understood and there are currently no suitable tools to study their generation, or the genes involved. This proposal aims to develop such tools in patient-derived tumor cells in an effort to identify novel targets for improved cancer treatments.